Pathways of oncogene-induced senescence at DNA replication forks

PROJECT SUMMARY/ABSTRACT
Oncogene-induced senescence (OIS) is triggered by aberrant activation of oncogenes such as the mutant form
of RAS and acts as a key barrier to inhibit the progression of preneoplastic lesions. OIS is accompanied by
elevated DNA replication stress and activation of the DNA damage response (DDR); seminal studies have shown
that replication-associated DNA damage is a prerequisite for establishing OIS, where cells must be actively
replicating leading to a rise in replication stress that triggers DDR in response to oncogene-induced DNA hyper-
replication. Conversely, bypass of OIS allows the proliferation and oncogenic transformation of damaged cells
with genome instability. While these ideas underscore OIS as an anti-cancer barrier imposed by DNA damage
checkpoints, the precise nature of oncogenic stimuli that culminate in aberrant DNA replication and activation of
the DDR at stalled replication forks remains elusive. In addition, whether there exists distinct cellular signaling
cascade that relays upstream oncogenic signaling to a replication fork to cause DNA replication fork instability
is yet to be discovered. In this application, we propose to explicate the mechanisms that link oncogene-induced
replication stress to DNA replication fork integrity. Specifically, we reason that TIMELESS (TIM) in the fork
protection complex, an essential scaffold of the replisome necessary for replication fork progression and
checkpoint activation, is a key determinant of OIS. Our preliminary data indicate that OIS induced by RAS
activation is associated with downregulation of TIM that is linked to a novel posttranslational modification, i.e.
PARP1-dependent polyADP-ribosylation, of TIM and its proteolytic degradation. We hypothesize that failure to
protect stalled forks via suppression of TIM activity is an oncogene-induced mechanism that contributes to the
accumulation of replication stress and DNA fork instability. We will use HRASG12V as a model oncogene to induce
OIS in non-transformed human fibroblasts. In the first aim, we will identify the mechanism of HRASG12V-induced
OIS established by TIM downregulation and determine the role of TIM knockdown in triggering DNA replication
fork instability and senescence. I will also investigate whether TIM overexpression overcomes DNA replication
fork instability, and thus the onset of OIS. A variety of molecular and cellular techniques will be employed,
including DNA combing analysis of DNA replication fork resection, to evaluate the capacity of TIM-depleted cells
to prevent fork degradation in response to oncogene activation. In the second aim, we will identify the mechanism
of TIM downregulation during OIS, focusing on characterizing the polyADP-ribosylation and proteolytic
degradation of TIM triggered by the HRASG12V-driven signaling cascade. In the third aim, we will elucidate the
role of TIM in promoting tumorigenesis in the Kras-driven prostate cancer organoid model to define TIM as a
major player of early oncogenic events to breach the OIS barrier and promote transformation in the context of
RAS activation. Together, we expect to reveal a new mechanism underlying the onset of OIS, ultimately defining
TIM as a target of cancer therapy to induce senescence of cancer cells.

Public health relevance
PROJECT NARRATIVE This study will provide mechanistic insight into how deprotection of stalled forks potentiates oncogene-induced senescence (OIS) and how pre-malignant cells under replication stress overcome OIS and establish oncogenic transformation. My study aims to lay the foundation for targeting TIM gain-of-function as a way to sensitize cancer cells to oncogene-induced DNA replication stress. Understanding the nature of TIM in OIS can pave new ways to inhibit TIM, resensitize cancer cells, and ultimately prevent tumorigenesis.